LR-IL-22 for Mitigation and Management of Radiation Injuries

Abstract:
Mitigation of damage caused by total body irradiation (TBI) or partial body irradiation (PBI) requires targeting
the acute gastrointestinal syndrome. Parenteral administration of radiation mitigators for the hematopoietic
syndrome may also ameliorate the gastrointestinal syndrome; however, drug delivery to the intestinal crypts is
ineffective due to irradiation damage to the intestinal microvasculature. We have demonstrated that oral
administration of engineered Lactobacillus reuteri, which produces and releases IL-22 (LR-IL-22), ameliorates
the TBI induced acute gastrointestinal syndrome. Effective mitigation is associated with preservation of Lgr5+
intestinal crypt stem cells and their regeneration capacity. We will now establish the underlying mechanism of
radiation mitigation by LR-IL-22, and will develop a microbial therapeutic with enhanced safety and efficacy.
Preliminary data demonstrate that LR-IL-22 restores irradiation-induced suppression of gene transcription in
Lgr5+ stem cells. TBI reduces expression of the aryl hydrocarbon receptor (AhR) in the intestine and its
generation of downstream products, including IL-22. We hypothesize that TBI-induced intestinal damage will
be further mitigated by combining LR-IL-22 with a probiotic (R2Ic) that naturally induces AhR to stimulate
recovery of intrinsic IL-22 levels. Furthermore, we will establish that priming the release of IL-22 by our
engineered probiotic increases therapeutic efficacy and the biological and environmental safety profiles. The
First Specific Aim tests the hypothesis that LR-IL-22 restores radiation suppressed transcription at the
molecular level in Lgr5+GFP+ intestinal stem cells. The Second Specific Aim tests the hypothesis that the
activation of AhR in irradiation weakened cells by LR-IL-22 is further boosted by oral gavage of R2Ic to induce
intrinsic IL-22 production. The Third Specific Aim addresses the need to provide biological and
environmental containment of LR-IL-22, while improving the therapeutic efficacy. Successful completion of the
proposed studies will lead to translation of LR-IL-22 to the National stockpile, as an effective mitigator of the
acute radiation induced gastrointestinal syndrome.

Public health relevance
Project Narrative: The total body irradiation induced acute gastrointestinal syndrome is mitigated by administration of an engineered probiotic bacterium Lactobacillus-reuteri, LR-IL-22, which anatomically targets the radiation damaged intestinal crypt stem cells to restore intestinal integrity and is superior to systemic/parenteral administration of IL-22. We have demonstrated that intraoral (gavage) of LR-IL-22 mitigates the gastrointestinal syndrome by restoring irradiation-suppressed gene transcription in intestinal stem cells. We will now establish that LR-IL-22 and a new improved version modulates irradiation-induced molecular biologic cell death pathways in intestinal stem cells, preserves their crypt regeneration capacity, and mitigates the irradiation- induced acute GI syndrome.